Nickel-Catalyzed Asymmetric Synthesis of Fully Saturated Nitrogen Heterocycles

? DESCRIPTION (provided by applicant): The enantioselective synthesis of fully saturated nitrogen heterocycles has received a significant amount of attention, owing to the plethora of medicinally relevant natural products and drugs containing this motif. Many of the established approaches focus on formation of the carbon-nitrogen bond and are inherently limited to the asymmetric synthesis of 2-substituted heterocycles. My proposed cyclization/cross-coupling methodology builds fully saturated heterocycles by construction of the C2-C3 bond, an underutilized strategy, and permits the enantioselective synthesis of substituted nitrogen heterocycles (3-substituted and 2,3-disubstituted pyrrolidines and piperidines) from racemic starting materials.

Public health relevance
PUBLIC HEALTH RELEVANCE: Fully saturated nitrogen-containing heterocycles are highly common motifs in organic chemistry and are found in many medicinally relevant compounds, including natural products and drugs. Their ability to occupy a well-defined three-dimensional environment allows this class of molecules to interact strongly with their highly specific biologicl target or enzyme. The challenge faced by chemists is to design selective reactions to mold molecules into the desired spatial topology to fit their receptors. The proposed methodology makes use of a nickel catalyst to transform readily available starting materials into drug-like molecules with complete three-dimensional control. The full impact of this reaction will be explored through the formation of several different classes of saturated heterocycles containing various substitution patterns, as well as the application towards the synthesis of the anti-HIV natural product, petrosin.